Community Engagement Core

ABSTRACT
The overarching goal of the community engagement core (CEC) of the Border Biomedical Research Center for
Hispanic Cancer Health Disparities (BBRC-HCHD) is to reduce and eliminate Hispanic cancer health
disparities through collaborative partnership, community based participatory research and dissemination
strategies. The CEC was established over four years ago to foster integrative research, translate and
disseminate findings, and to partner with the RCMI RTRN. Since then, the CEC has been developing and
nurturing bidirectional community partnerships to facilitate the translation of scientific findings, maximize
resources, and increase the community’s capacity for research. The CEC will continue its work to expand
bidirectional, binational partnerships between BBRC-HCHD researchers, community collaborators, and
stakeholders to gain insight into the expressed health-related needs of the region. These collaborations will
facilitate biomedical and behavioral research that will expand the scope and breadth of the BBRC-HCHD.
Targeted strategies will drive the proposed efforts and are delineated in three Specific Aims: 1) Create and
foster meaningful partnerships to expand the breadth/scope of BBRC-HCHD collaborations to facilitate
community engaged research addressing expressed health-related needs and priorities, 2) Leverage
opportunities to engage, recruit, and retain participants in research studies within our predominantly Hispanic
population of Mexican origin, and 3) Augment culturally and linguistically sensitive dissemination strategies of
research results by partnering with community collaborators and stakeholders to reach our undeserved and
rural communities. In order to accomplish the proposed work, the CEC will utilize community based
participatory research strategies, and evaluation methods. Implementation of the proposed work will be multi-
pronged, utilizing multi-media technology and face-to-face contact. A promotores de salud/Community Health
Worker (CHW) model will be included as one of the proposed strategies to reach underserved community
members in a culturally and linguistically sensitive manner, to facilitate community outreach and dissemination
efforts at a “grass roots” level.